MFRPS Maintenance - Florida Department of Agriculture and Consumer Services/FDACS

Project Summary
The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food
Safety has been enrolled in the Manufactured Food Regulatory Program Standards (MFRPS)
since 2008 and in full conformance with all 10 standards since 2016. In this time, FDACS has
implemented many systems within the MFRPS program. This project proposes to build on those
systems as the department continues to improve, maintain, and enhance existing systems.
This cooperative agreement will afford us the opportunity to maintain full conformance with the
MFRPS and to share, collaborate, and mentor other state programs as we continue develop
creative and innovative solutions for the program. Proposed work for this project includes
enhancing inspection and training systems, updating electronic systems to improve data
exchange capabilities, developing mutual reliance efforts, and improving upon on the
established foundation. The end project goal is to strengthen consistency, effectiveness, and
efficiencies of developed and new systems used to enhance strengthening of the integrated
food safety system, resulting in a safe food supply for the public

Public health relevance
Project Narrative The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food Safety seeks to continue their involvement in the Manufactured Food Regulatory Program Standards (MFRPS). FDACS is committed to continued improvement, enhancement, and maintenance of the manufactured food program, as well as assisting with improvements of other programs nationwide. These improvements will strengthen the integrated food safety system, resulting in a safer food supply for the public.